R25 Fisk-Vanderbilt Bridge to the Biomedical PhD R25-BMP

The overall goal of the Fisk-Vanderbilt R25 Bridge to the Biomedical PhD Program (R25-BMP) is
to provide research experiences, coursework and professional development training to assure at
least 70% of trainees transition to PhD granting programs at Vanderbilt or other institutions
nationally, and more than 80% of those who transition to the PhD complete the degree. This
proposal adds a number of innovative strategies to the original R25 programming, based on
lessons learned, including: 1) direct linkage of the Biomedical Track in the Fisk Master’s phase to
Vanderbilt’s Interdisciplinary Graduate Program, specifically the embedded Vanderbilt Initiative
for Maximizing Student Development (IMSD) Program, linked to 16 possible bio-medically
relevant PhD-granting programs; 2) embedding incoming Master’s trainees in IMSD student led
data/journal clubs the Fall of their first year; 3) participation in the Bio-regulation course, required
of all VU biomedical PhD programs, during year two of the Master’s for PhD-level credit for
students who earn a B or higher; 4) National Networking Liaisons at research focused institutions
where our Biomedical Bridge trainees have transitioned previously and/or whose research areas
align with the Master’s phase research, and 5) IMSD peer mentors connected to Master’s phase
trainees from the start of their first year.

Public health relevance
Project Narrative : The revised continuation of the Fisk-Vanderbilt R25 BMP Bridge to the Biomedical PhD program has the goal of assuring at least 70% of R25 students’ transition to a PhD program, and that more than 80% of those persist to the PhD. To assure continuing success in biomedical research careers, this program introduced innovative strategies to link Fisk Master’s trainees to a national Network Liaison team while at the same time embedding incoming Master’s trainees in the Vanderbilt IMSD Program with peer mentors and early engagement in the NIH-funded Initiative for Maximizing Student Development ( IMSD)-hosted activities for PhD Trainees at Vanderbilt. To accelerate progress to the PhD, trainees will participate in the Vanderbilt BioRegulation course during their second year in the Master’s- a course required of all PhD trainees in the biomedical sciences at Vanderbilt.